Lipid storage and catabolism as drivers of metastatic invasion

Metastasis is the primary cause of cancer death, yet therapeutic strategies to inhibit metastatic invasion do not
exist. The long-term goal of our research program is to define the molecular mechanisms driving metastatic
invasion, with the goal of identifying novel therapeutic targets and strategies to improve cancer survival. While
tumor cells are known to undergo metabolic reprogramming to support tumor growth, the metabolic drivers of
metastasis are poorly understood. This proposed research will define how stored lipids are used as a fuel
source to power metastatic invasion in pancreatic cancer. We have preliminary data that pancreatic tumor cells
undergo a shift towards lipid storage, and that this is required for invasion. This occurs through a suppression
of the hormone sensitive lipase (HSL) by the oncogene KRAS, leading to lipid accumulation and priming tumor
cells for metastasis. These stored lipid droplets are then catabolized during the process of invasion via the
action of lipases. This results in increased oxidative metabolism in the most migratory cells, thereby
coordinating lipid droplet breakdown and fatty acid oxidation with cell migration. These data lead to the
hypothesis for this proposed research that PDAC cells undergo a metabolic shift to favor the accumulation
and storage of lipid droplets, which are catabolized during invasive migration to fuel oxidative phosphorylation
to power metastasis. Using a combination of cell biology, biochemistry, and in vivo models, we will test this
hypothesis by defining the mechanisms of lipase suppression leading to lipid droplet storage (Aim 1), and the
coordinated and localized activation of lipolysis to drive tumor cell invasion (Aim 2). Successful completion of
this research will provide fundamental advances in defining the metabolic pathways regulating invasive
migration, with a focus on lipid droplets, and with the goal of identifying metabolic vulnerabilities in tumor cells
that will provide targets for therapy to block metastasis and improve survival.

Public health relevance
Metastasis, the spread of cancer throughout the body, is one of the primary causes of cancer death, yet there are no therapeutic strategies to inhibit metastatic invasion. Cancer cells are known to undergo metabolic reprogramming to promote tumor growth, but the metabolic drivers of metastasis are unknown. This research will define the how lipid storage and catabolism fuel metastatic invasion in pancreatic cancer.